THE EFFECTS OF HIGH DOSE SIMVASTATIN IN PRIMARY HYPERCHOLESTEROLEMIA

This study will compare the hypolipidemic effects, influence on lipoprotein and cholesterol metabolism on gemfibrozil, simvastatin and atorvastatin in patients with type III hyperlipidemia. After a 4 week dietary baseline, patients will be treated in a random sequence with gemfibrozil, simvastatin or atorvastatin each for 8 weeks; efficacy, metabolic effects and safety will be evaluated on each regimen.